Distinct roles of neural crest cell populations in cranial suture development and disease

PROJECT SUMMARY
Cranial sutures are fibrous joints that separate the flat bones of the skull; they coordinate growth of the brain and
the overlying calvarium. Premature fusion of sutures, known as craniosynostosis, affects 1:2,250 (148,000)
children each year. Synostosis causes facial deformities, skull defects, and brain damage via intracranial
pressure. Surgical intervention is the most common treatment, often as a suite of corrective postoperative
refusion surgeries, each of which increases patient morbidity and mortality. Thus, patients and their families
experience profound physical, cognitive, social, and financial burdens. A biological therapeutic that resolves
suture fusions in vivo is not yet identified, perhaps because a long-standing question in the field is why do post-
operative fusions occur? One often affected tissue that holds osteogenic potential to induce calvarial ossifications
is the underlying meninges, which segregates the brain from the calvarial bone. The meninges, composed of
neural crest and mesoderm lineages, plays an instructive role in calvarial healing, suture patency, and closure,
but how the meninges regulate the development and maintenance of the overlying sutures remains unknown.
Fibroblast growth factor (FGF) signaling makes up 50% (74,000 cases annually) of syndromes that result in
premature skull fusion, including Crouzon, Beare-Stevenson, Bent Bone Dysplasia (BBDS), Apert and Pfeiffer.
The latter two syndromes are among the most severe. All five syndromes result from gain-of-function mutations
in FGF Receptor 2 (FGFR2; 32%). The involvement of FGFR2 in several congenital disorders underscores this
gene’s clinical relevance [17-23]. Therefore, a deeper understanding of the diseased state of the receptor is
necessitated for breakthroughs in therapeutics that will attenuate skull fusions and reduce the need for multiple
surgeries. FGFR2 is highly expressed at the suture bone fronts and throughout the underlying meninges; yet the
role of FGFR2 in the meninges is not well understood. Mouse conditional activation of nuclear Fgfr2 (BBDS
allele) in neural crest cells result in progressive multi-suture synostosis, with meningeal neural crest contribution
to mesoderm-derived bones. But the identity of the populations that cross the neural crest-mesoderm boundary,
are unknown. To understand the neural crest/meningeal regulation of the suture, I will employ the mouse
conditional allele, Fgfr2IIIcΔ/+, because it mimics more severe forms of synostoses, BBDS, Apert and Pfeiffer’s.
Therefore, I will test the hypothesis that distinct neural crest populations expressing Fgfr2IIIcΔ/+ during
development induce synostosis by reducing the levels of CCN2, a patency inducer, near cranial sutures. In Aim
1, I will determine the role of neural crest-derivatives in Fgfr2IIIcΔ/+ -mediated synostosis. In Aim 2, I will
determine whether overexpression of the Fgfr2 noncanonical inhibitor, CTGF/CCN2, in distinct neural crest
populations resolves Fgfr2IIIcΔ/+-mediated synostosis during development and adulthood. Completion of this
study will reveal the role of neural crest cell/meninges in suture development, congenital disease, and will
identify candidate biological therapeutics for suture regeneration.

Public health relevance
PROJECT NARRATIVE Craniosynostosis, the fusion of skull and facial bones, is among the most common of childbirth defects (148,000 cases per year) that limits the lifespan, physical growth, and cognitive development of children. Patients suffer several corrective post-operative refusion surgeries. While the conserved signals that maintain separate skull bones remain unknown, my findings will reveal the cellular basis of premature skull fusions in Bent Bone Dysplasia, Apert and Pfeiffer syndromes, three human disorders that cause devastating skull deformities and neonatal death.